Centrifugal microfluidic system for functional cellular analysis

Spheroids and organoids are self-assembled, multicellular, 3D structures that better mimic in vivo tissues than
2D cell cultures. They have become an indispensable in vitro tool for processes such as drug assays, disease
modeling, and for mechanistic studies. The secretion of specific factors by spheroids and organoids is vital for
accurate recapitulation of in vivo function. Methods to measure secretion from these in vitro systems are indirect,
slow, laborious, and combine many spheroids / organoids together masking the dynamics of secretion from the
individuals. In this proposal, we will develop technology that will enable online measurement of secretion
dynamics from many individual spheroids or organoids in parallel. To accomplish this work, we will perform the
following specific aims. In aim 1, a centrifugal system will be developed to deliver a continuous flow of perfusion
solution to spheroids / organoids as well as immunoassay assay reagents specific for the secreted factor of
interest. These solutions will be delivered via centrifugal pumping to a mixing channel where fluorescence
anisotropy will be used to quantify the secreted factor as the device spins. The spinning system and fluorescence
anisotropy system will be fully optimized. In aim 2, this system will be applied to several model spheroid systems
for validation of the technology. The system will enable quantitative measurement of secretory function multiple
times per second from each organoid, making a significant and vertical advance compared to current technology.
We anticipate the new technology will be a powerful tool in the field of spheroid and organoid research.

Public health relevance
The proposed research is relevant to public health because developing methods to measure the secretory dynamics from spheroids and organoids is ultimately expected to help those researchers developing these tissues for mimicking in vivo function and increase understanding of the pathogenesis of perturbed secretions observed in various disease states. The proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that enhances human health.